Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT – LEADERSHIP, PLANNING, AND EVALUATION
The Fox Chase Cancer Center (FCCC) has established an expanded, highly effective leadership team and
structure for planning and evaluation. The FCCC Director, Chernoff assembled a new team shortly after his
appointment as Director in 2021. The FCCC Cancer Center Leadership Committee (CCLC) consists of the
Director, along with the Deputy Director, Chief Scientific Officer, and Associate Directors. The CCLC and
Chernoff are the FCCC's policy-making body, establishing the vision for the Center and ensuring that FCCC
meets its strategic goals to enhance cancer research that impacts the population of its catchment area (CA).
Under the leadership of Chernoff, the CCLC revised and continues to monitor the efficacy of the FCCC research
programs, shared resources, membership, community outreach and engagement, training, and education and
commitment to diversity, equity, inclusion, and access. The CCLC utilizes internal and external advice to
effectively plan and evaluate new programmatic initiatives, faculty recruitment, shared resources, foster team
science and exploit opportunities to advance the FCCC’s progress. In 2022, with input from internal and external
stakeholders, the CCLC began to implement the Center’s new strategic plan, which comprises a roadmap to
invest in and develop Center priorities in alignment with its revitalized relationship with Temple University Health
System (TUHS) and Temple University (TU), and the CA priorities. The plan, which was endorsed by the External
Advisory Board (EAB), guided the leadership to transform cancer research at FCCC by creating a collaborative
culture focused on discovery. In doing so, Chernoff has acquired and invested significant new institutional
support to recruit new faculty, improve infrastructure, enhance shared resources, reorganize and expand clinical
trial capabilities, expand community outreach with the advice of the Community Advisory Board, enhance training
and education, formulate a Plan to Enhance Diversity, and develop mechanisms to bring FCCC discovery into
the clinic. Accomplishments since 2019, driven by the new strategic plan, include: 1) Program reorganization
resulting in two new programs 2) recruitment of 31 new faculty, 3) NCI funding increased by 12%, from $9.6M to
$10.7M (DC), 4) Peer-reviewed funding increased by 21%, from $20.4M to $24.8M (DC). 5) Publication output
increased from 1971 in the 2014-2019 funding period to 2,401 in this period, with an increase in high impact (IF
>10) publications from 580 to 635. 6) Accruals to all interventional trials increased from 1,410 in 2019 to 1,809
in 2023, with treatment trial accruals increasing from 540 to 690, representing ~11.3% of newly registered cases.
7) IIT accrual accounted for 76% of interventional enrollments and 63% of treatment enrollments and included
translation of multiple FCCC discoveries into the clinic. and 8) Improved integration across all three FCCC
campuses with appointment of two new senior leaders and more intentional focus on collaboration. Under
Chernoff’s direction and strong leadership team, guided by the new strategic plan, enhanced integration with TU
and with strong institutional support, a continued upward trajectory of progress is expected at FCCC.